Novel Paxillin-FAK Inhibitors for the Treatment of Liver Fibrosis

Abstract
Chronic liver diseases like metabolic dysfunction-associated steatohepatitis (MASH), alcoholic liver disease
(ALD), and viral hepatitis afflict more than 4.5 million Americans and are a major cause of death in those over
45. These diseases are associated with the development of liver fibrosis, which can lead to cirrhosis,
hepatocellular carcinoma (HCC), and liver failure, necessitating liver transplantation or resulting in death. There
are currently no FDA-approved therapies for modifying the progression of liver fibrosis, making this a significant,
unmet medical need. Quiescent hepatic stellate cells (HSC) become activated after injury and produce excessive
extracellular matrix (ECM) material. Paxillin is a key adaptor protein in recruiting multiple regulatory proteins,
mediating downstream signaling, and linking the ECM to the cell cytoskeleton. Among its binding partners, focal
adhesion kinase (FAK), a nonreceptor tyrosine kinase and scaffolding protein, is a highly promising target in liver
fibrosis, along with paxillin, due to its key role in promoting HSC activation. Acting downstream of transforming
growth factor beta-1 (TGF-β1), paxillin upregulation and FAK activation induce HSC activation, myofibroblast
differentiation, the formation of stress fibers, and the upregulation of ECM proteins. Notably, paxillin
downregulation and FAK inhibition attenuate liver fibrosis in animal models. Unfortunately, FAK-kinase domain
inhibitors have shown only partial effects and poor selectivity in non-fibrosis indications, which is independent of
its major role as a paxillin-binding partner and scaffolding protein. Furthermore, FAK-kinase inhibitors have
shown significant toxicity due to the conserved ATP-binding pocket and off-target effects. Through the interaction
with paxillin, FAK localizes to focal adhesions and regulates the focal adhesion complex. Therefore, peptide
inhibitors targeting paxillin-FAK interaction may show greater efficacy and safety than FAK-kinase inhibitors.
FAKnostics has identified a first-in-class series of peptidic inhibitors that directly target the paxillin-FAK
interaction. FAKnostics’ novel peptides have 100-fold higher potency at binding the FAK than the native paxillin
LD2 peptide motif. The ability of these candidates to inhibit the downstream effects of FAK activation has been
confirmed in vivo in a syngeneic mouse model of melanoma. However, the effect of paxillin-FAK inhibition on
the profibrogenic effects has not yet been fully evaluated. This Fast Track STTR aims to demonstrate proof-of-
concept for use of these novel peptidic inhibitors in the treatment of liver fibrosis and to identify a preclinical
candidate for future development. In Phase I, FAKnostics will optimize lead peptides to improve the
biophysical/biochemical activity, characterize peptides in vitro, and confirm efficacy in an animal model of liver
fibrosis. Phase II will include evaluation of ADMET properties, development of a long-lasting subcutaneous
formulation, PK/safety studies, and comprehensive efficacy validation in liver fibrosis models. This will enable
future completion of additional IND-enabling and manufacturing work to advance novel peptide drugs to the clinic.

Public health relevance
Narrative Chronic liver diseases are a major public health concern, affecting over 4.5 million Americans and resulting in untreatable liver fibrosis, which can progress to cirrhosis, hepatocellular carcinoma, and ultimately liver failure and death. FAKnostics is developing novel inhibitors that block paxillin interactions with focal adhesion kinase (FAK), which acts downstream of master profibrogenic regulator TGF-β to activate hepatic stellate cells and promote fibrosis. Successful inhibition of paxillin-FAK could interrupt the fibrogenic cascade, attenuating the development of liver fibrosis and leading to the first effective therapy capable of modifying the progression of chronic liver disease.